microRNA-204 and microRNA-211 regulation of RPE phagocytosis

PROJECT SUMMARY/ABSTRACT
Age-related macular degeneration (AMD) is a disease that leads to the loss of visual acuity, resulting in a
substantial medical and social burden. Many unique pathways lead to the pathogenesis of AMD.
The retinal pigment epithelium (RPE) is a post-mitotic epithelial monolayer which sits directly adjacent to the
photoreceptor outer segments (POS) and is responsible for the maintenance of photoreceptor health. Among
its functions include the generation of 11-cis-retinal chromophore for phototransduction, nutrient delivery, and
diurnal phagocytosis of spent POS. Degeneration and dysfunction in the RPE is linked to the subsequent
decline in photoreceptors seen in diseases such as AMD and Leber’s congenital amaurosis.
Therefore, understanding RPE dysfunction is critical to understanding overall retinal health, but regulation of
these key RPE roles is still incompletely understood. Recent research has pointed to the important role of
microRNA (miR) regulation of gene expression, and miRs are critical for ophthalmic development and
homeostasis. Of these miRs, miR-204 and miR-211 are among the most highly expressed miRs in the RPE
and have been shown to both maintain its epithelial properties and modulate endosomal/lysosomal processing.
These two miRs share the same seed sequence and are hypothesized to regulate many of the same genes,
and are themselves regulated by light and the circadian clock. Previous studies have implicated the expression
of these miRs in the control of RPE phagocytosis, but this has not been fully tested in a RPE specific manner.
Thus, this proposal will examine the role(s) of miR-204 and miR-211 in an RPE specific manner and test the
hypothesis that these two miRs regulate RPE phagocytosis. To pursue these objectives, we have generated
miR-204fl/fl and miR-211fl/fl double knock-in mice. Induction of recombination in double knock-in mice will be
achieved by (1) crossing them with RPE65-ERT2-cre mice and inducing recombination in the resultant triple
knock-in mice by intraperitoneal injection of tamoxifen; and (2) subretinal delivery of AAV1-CMV-cre-GFP. The
miR double knockout mice will be aged and assessed for phenotypic, electrophysiological, and histological
changes. RPE and retina from these mice will also be collected and analyzed through bulk and single cell RNA
sequencing to examine changes in gene expression resulting from miR-204/miR-211 deletion. The direct
target genes of these two miRs will be assessed through the application of Halo-enhanced Ago2 pulldown
(HEAP). We will also perform the in vitro culture of double knock-in mouse RPE and challenge them with POS
to assess their phagocytic capacity. Lastly, we will correlate the results for mouse RPE to analogous results for
human RPE through the use of RPE cultures derived from induced pluripotent stem cells. Overall, these
studies will seek to define the role(s) of miR-204 and miR-211 in the RPE, identify their regulated genes, and
suggest further genes and pathways to target in the development of AMD therapeutics and diagnostics.

Public health relevance
PROJECT NARRATIVE The retinal pigment epithelium (RPE) is critical to maintaining our vision, and degeneration of the RPE can lead to irreversible vision loss. This research will examine the basic biology of the RPE and how it supports the health of the retina, allowing our eyes to turn light into a signal that we can perceive as sight. Knowledge of how these processes work is expected to inform the development of therapeutics to combat age-related and genetic blinding diseases.